3/3 Sequencing and Trans-Diagnostic Phenotyping of Severe Mental Illness in Diverse Populations

Project Summary
In this new and unfunded study, we will capitalize on the lessons from the past 15 years of psychiatric
genomic. Based on these lessons, we propose an exceptionally novel and important set of aims to further
knowledge of the genetic architecture of mental illness. We propose to perform whole-exome sequencing and
SNP-array genotyping on >150,000 cases with severe psychiatric disorders along with a similar number of
controls. It will be large, transdiagnostic, based on patients seen in clinical psychiatry, and comprehensively
analyze ultra-rare exonic, rare copy number, and common variation. Because assay costs are prohibitive (on
the order of $US 80 million), we are partnering with Regeneron Genomics Center (RGC) that will conduct all
genomic assays. NIMH funding is within the $500K direct cost cap at each site.
We will: (1) Acquire samples with clinically severe psychiatric disorders. Cases will have lifetime diagnoses of
schizophrenia (SCZ), schizoaffective disorder (SAD), bipolar I disorder (BD1), or severe major depressive
disorder (sevMDD). Roles: UNC is responsible for data coordination; the sampling sites are ISMMS (the
Americas and East Asia) and Cardiff (Europe, Africa, and South Asia) and each will collate samples (i.e.,
MTAs, ethical approvals, individual consent, harmonize phenotypes, QC DNA). Phase 1 (Years 1-2) will focus
on existing samples (N=100K cases). Phase 2 (Years 1-4) will focus on obtaining new samples (N=50K
cases), and will enable colleagues from low-income countries to obtain genetic data that would otherwise be
impossible. This will help those investigators and greatly increase diversity in genomics research. 2) Genomic
assays (Years 1-4). Samples will be sent to RGC in batches from ISMMS and Cardiff. RGC will generate whole
exome sequencing and SNP array data. UNC and RGC will jointly conduct alignment, QC, variant calling
(SNVs, indels, SVs), and array processing (common SNPs, imputation and CNVs). QC includes assessment of
multiple biases and comparison to independent datasets. Deliverable: analysis-ready data frames for rare
exonic, rare CNV, and common genetic variation. 3) Analysis for substantive scientific aims. Briefly, the main
analytical themes are to identify genetic variation associated with: (a) severe mental illness, (b) specific
disorders, and (c) cross-cutting clinical features (e.g., psychosis, treatment resistance, mania, ID). All analyses
will be conducted using robust methods/bias control, formally compared to relevant prior studies, and evaluate
the impact of all types of measured genetic variation across diverse genetic ancestries. 4) Data sharing will
align with NIMH policies via the NIMH Data Archive.
Successful completion of the proposed work will markedly increase the number of genes pinpointed by
burdens of rare coding variation, rare CNVs, as well as less specific GWAS associations–we will markedly
increase knowledge of the genetic architectures of these critically important and burdensome disorders.

Public health relevance
Project Narrative / Relevance Severe psychiatric disorders cause enormous human suffering, costs, and risk of death. Although we have learned a lot about the genetic causes, we urgently need to pinpoint many more specific genes. This new knowledge will inform the development of new therapies.